Multi-organism platform for functional analysis of Undiagnosed Diseases Network (UDN) variants

Project Summary This application proposes the Washington University in St. Louis School of Medicine (WUSM) Model Organism Screening Core (wuMOSC) as a key asset for Phase II of the NIH Undiagnosed Diseases Network (UDN). The wuMOSC will evaluate the pathogenicity of 200 genetic variants per year identified by UDN Clinical Sites in otherwise undiagnosed participants by leveraging the optimal combination of the following four animal model organisms and human cell-­based Resource Cores: 1) C. elegans, 2) Drosophila, 3) zebrafish, and 4) human pluripotent stem cells (hPSCs). This multi-­organism approach capitalizes on the experimental advantages of these four model systems, while avoiding the limitations of individual models. Extending the established advantages of the Drosophila and zebrafish, C. elegans allows for extremely rapid and cost-­effective variant evaluation, while hPSCs enable assessment of genes and variants that are not conserved in animal models. An experienced Leadership Team has been assembled that harnesses the collaborative research environment at WUSM, including the expertise of the McDonnell Genome Institute, and the superb WUSM clinical partners that constitute the proposed UDN Phase II WUSM Sequencing Center and Clinical Site applications, respectively. Using proven, cutting-­edge, and novel bioinformatic approaches, combined with thoughtful consideration of the advantages and limitations of each model organism, a careful assessment plan has been defined for determining the putative pathogenicity of nominated variants and prioritizing them for experimental evaluation by the Resource Cores. Preliminary data demonstrate that all four Resource Cores are using efficient and advanced genetic targeting techniques, including CRISPR/Cas9 to knock-­in the human variant into an orthologous gene, knock-­down and loss-­of-­function assays where appropriate, and overexpression to assess rescue of loss-­of-­function or for gain-­of-­function. Phenotypic analysis of the genetic models will be guided by information in model organism databases and the literature, as well as patient symptoms. This information will then be applied to the organism-­specific and extensive phenotyping pipelines. The UDN Clinical Sites, Steering Committee, and Coordinating Committee will receive frequent communications regarding plans and results of the wuMOSC, through the activity of the Administrative Core, which will also disseminate acquired model organism expertise to the wider NIH and other research communities. Therefore, the multi-­model organism wuMOSC will have an exceptionally high impact on the diagnostic efforts of the UDN by bioinformatically and experimentally evaluating the potential of disease-­causing variants in the context of disease-­specific phenotypes.

Public health relevance
Project Narrative The mission of the UDN is to make diagnoses in hard to diagnose patients, which is an essential step towards treatment. The Washington University Model Organism Screening Center (wuMOSC) will exploit the strengths of four model systems (C. elegans, Drosophila, Zebrafish and human pluripotent stem cells) for informative, efficient and cost-effective analysis of UDN gene variants. Experimental analysis in a model system will uncover the effect of the patient variant in the orthologous gene, providing important functional evidence that can inform diagnosis.